CRCNS Circuit-Level Mechanisms of Adaptive decision-making

Mammals continuously adapt the process of action selection in noisy and volatile environments to maximize
the success of future decisions by either selecting actions that are likely to return a desirable result
(exploitation) or taking a risk on something new to see if that will produce a better outcome (exploration).
This flexible decision-making is mediated by cortico-basal-ganglia-thalamic (CBGT) circuits that both control
action selection and use feedback signals to modify the approach to future decisions (i.e., undergo
reinforcement learning; RL). Dysfunction in how these pathways use feedback to guide future decisions is a
primary mechanism for many addictive behaviors (e.g., opioid addiction, obesity). Despite the fact that
decision-making and RL originate from a common neural substrate, they are generally studied as
independent processes. Understanding the unified nature of action selection and learning requires a careful
re-evaluation of how cognitive algorithms emerge from the circuit-level dynamics of CBGT networks.
We propose a series of empirical and theoretical investigations that bridge across levels of analysis to unify
algorithmic models of learning and decision-making in order to understand how CBGT networks use
feedback to manage the trade-off between exploration and exploitation. Our first step toward achieving this
goal will be to develop a computational “upwards mapping” framework that links cognitive process models
with biologically realistic spiking models of CBGT networks under constraints imposed by existing behavioral
observations from a set of adaptive decision-making experiments. This approach will allow us to derive
testable predictions about how different CBGT network properties (e.g., population activity levels or pathway
connection strengths) scale cognitive processes (e.g., evidence accumulation rate) to produce distinct
phenotypes of decision policies (Specific Aim 1a). Using this paradigm we will also generate predictions about
how, under changing conditions, neural plasticity mechanisms can adaptively shift CBGT networks into
distinct states that manage the exploration-exploitation trade-off in contextually appropriate ways (Specific
Aim 1b). Predictions will be tested experimentally using recordings in multiple key CBGT sites as well as
optogenetic perturbation of striatal and subthalamic nucleus targets in rodents performing a 2-armed bandit
task with static or variable action-outcome contingencies (Specific Aim 2).
RELEVANCE (See instructions):
Dysfunction in how the brain uses feedback to guide future decisions is a primary mechanism for many public health
problems (e.g., addiction, cardiovascular disease). This research program will provide new insights into how neural
circuits give rise to decision-making in humans and other mammals and how environmental contexts (e.g., volatility
of reward schedules) regulate brain network configurations to produce behavioral flexibility. This information can
provide key insights into the neural systems that give rise to addictive behaviors and other public health problems.